Core--Clinical

The Clinical Core is an essential component of this grant. The Clinical Core will have two basic[unreadable] responsibilities.[unreadable] 1) The first is the extraction and inputting of data into the DeKAF database, both clinical data from the study[unreadable] sites, and inclusion of genotyping results from the Genotyping Core. This will also include maintenance of the[unreadable] database as it applies to this project and quality control of the data, sample tracking and assurance of HIPPA[unreadable] compliance. It should be noted that the majority of the clinical outcome data will come from the DeKAF[unreadable] project, but additional data will be collected.[unreadable] 2) The second will be to provide statistical support to the two projects, including reports for Projects by Israni and Jacobson.